Administration

The Administrative Core will provide executive oversight and administrative support for all of the projects and cores that comprise the Genomics of Acute Myelogenous Leukemia (GAML) Program Project Grant. The goal of the Administrative Core is to monitor the activities of all of the program components, to comply with all local and federal guideline for grant administration, and to facilitate communication and collaboration among the program members. Accordingly, the specific aims of the Administrative Core are as follows: Specific Aim 1: We will facilitate communication and collaboration among investigators. We will provide administrative oversight and support for all projects and cores. We will provide budgetary management for all projects and cores. We will coordinate all GAML PPG-related meetings, including Advisory Board member visits. Specific Aim 2: Specific Aim 3: Specific Aim 4: